Mechanism of yeast gene regulation

PROJECT SUMMARY
The mechanisms by which eukaryotes regulate gene expression are important for understanding many
complex biological phenomena including human diseases. Prevention and treatment of such diseases have
been and will continue to be improved by basic knowledge of gene regulation, especially because molecular
mechanisms of transcriptional initiation are highly conserved in eukaryotic organisms ranging from human to
yeast. This proposal will continue to investigate basic issues concerning molecular mechanisms of cleavage/
polyadenylation (3’ end formation), and mRNA stability in yeast, by combining molecular genetic, and
functional genomic approaches. It will take advantage of our novel methodologies for measuring half-lives,
structure (DREADS via chemical probes), protein binding (CLIP-READS), and poly(A) length (A-READS) of
individual mRNA 3’ isoforms. Our previous work identified strong and unexpected mechanistic links between
transcriptional elongation, cleavage/polyadenylation, and mRNA decay. Novel findings include a nucleotide-
level link between elongation and cleavage/polyadenylation, condition-specific 3’ isoform half-lives and mRNA
stability elements, and a compensatory mechanism in which the rate of cleavage/polyadenylation in the
nucleus is linked to 3’ isoform stability in the cytoplasm. The proposed experiments represent a highly
integrated approach to study the generation, structure, stability, and regulation of 3’ isoforms on a
transcriptome scale. In addition to our previous experiments that involved relatively stable cytoplasmic
mRNAs, the new studies will use a metabolically labeling, pulse-chase approach to analyze newly-synthesized
RNAs that are generated in the nucleus prior to transport to the cytoplasm. First, for polyadenylation, we will
(A) define the sequence requirements for 3’UTRs by generating large libraries of yeast cells each of which
contains a genetically modified 3’UTR, B) use the 3’UTR cell libraries to address the mechanism(s) by which
polyadenylation is restricted to the 3' UTR. C) identify factors that are responsible for the wild-type poly(A)
pattern, D) determine the mechanistic basis for how individual proteins involved in transcriptional elongation,
cleavage/polyadenylation, and mRNA decay affect poly(A) profiles of some genes but not others, and E)
elucidate 3'-isoform variation and regulation of poly(A) tail length. Second, for studies of mRNA
stabilization/destabilization elements and half-lives of 3' isoforms, we will A) perform RNA structural analysis
during the degradation process, B) identify proteins that affect/mediate the large differences in mRNA isoform
stabilities C) perform directed genetic experiments to address how secondary structure affects mRNA stability,
D) elucidate our recently discovered compensatory mechanism between cleavage/polyadenylation and mRNA
decay, E) identify isoform-selective mRNA-binding proteins, and F) investigate the mechanism of condition-
specific isoform half-lives and stability elements that we recently identified. Overall, the proposal will answer
fundamental questions about the interlinked processes of transcription, polyadenylation, and mRNA stability.

Public health relevance
PROJECT NARRATIVE Regulation of gene expression is a critical aspect of many biological phenomena (e.g. cell growth, development of multicellular organisms, the response to environmental conditions, and evolution), and alteration of normal gene regulation can lead to human disease. This proposal investigates fundamental molecular mechanisms of gene regulation at several levels including the relationships between transcriptional elongation, cleavage/polyadenylation (3' end formation), and mRNA stability. The results will continue to shed new light on fundamental issues in gene regulation and will have a significant impact on our understanding of human biology and disease.